Data Management Core for SWOG SDMC

Project Summary/Abstract
Data Management Core
The Data Management Core is responsible for both the data management and computing needs of the SWOG
SDMC. The Data Management Core provides management processes and procedures for delivering high quality
and timely data on clinical trials. Specific goals include the following: (a) develop and optimize systems for the
complete and timely collection, review, secure storage and retrieval of the highest quality data, complementing
Medidata Rave and other standardized NCTN tools; (b) ensure timely and accurate adverse event monitoring
and reporting; and (c) enhance existing and develop new software to best track patient specimens and
translational medicine data and expand the use of the SWOG biorepository to the research community.
The SWOG SDMC, primarily through the Data Management Core, facilitates these activities to ensure high
quality and timely data using improved data forms, standardized data definitions, and reporting systems to
maximize accuracy, and by providing education to investigators and site oncology research professionals on
best practices for data management and electronic data capture principles.
The SWOG Data Management Core has a significant history of developing high quality and innovative cross-trial software programs to enhance existing NCI tools to best manage data activities.